Outreach, Recruitment and Engagement Core

PROJECT SUMMARY/ABSTRACT - OUTREACH, RECRUITMENT AND ENGAGEMENT CORE
The Outreach, Recruitment, and Engagement (ORE) Core serves an essential role in the
Mayo Clinic Alzheimer's Disease Research Center (ADRC) by: (1) facilitating recruitment and
retention of diverse participants into the clinical, neuroimaging, biomarker, and neuropathology
studies of center, (2) developing and evaluating innovative support programs for persons with
Alzheimer's disease (AD) & AD-related disorders (ADRD) and their loved ones, and (3) advancing
efforts to raise awareness and prepare communities to better manage and support residents with AD
& ADRD and their families through community-based solutions. Operating at two geographically
distinct sites in a coordinated fashion, ORE Core efforts meet center goals through targeted, site-
specific activities in Jacksonville, FL (MCF) and Rochester, MN (MCR). Overall center recruitment is
managed through the clinical practices of Clinical Core investigators, allowing ORE Core to focus
recruitment efforts specifically on African Americans in the local Jacksonville community. These
efforts are supported through activities and events developed and delivered in partnership with the
Mayo Clinic ADRC African American Community Outreach & Advisory Board, the executive board
and Vision Keepers of Jacksonville's New Town Success Zone, the City of Jacksonville's Dementia
Care & Cure Initiative, the Central & North Florida chapter of the Alzheimer's Association, and local
caregiver support agencies. We will foster retention of African American participants through a new
collaborative effort with Clinical Core to provide advanced care planning services for these
participants. To foster retention and inform best practices in patient and caregiver education, MCR
ORE Core will continue to develop and refine innovative care programs in which participants will play
a central role in identifying goals and evaluating outcomes. These efforts will focus primarily on
persons with Lewy Body Disorders and Frontotemporal Dementia to reflect our center theme of
Similarities and Differences Among Neurodegenerative Diseases. Retention events such as annual
participant appreciation luncheons will continue at both sites. To increase community awareness and
address threats to the well-being of persons with AD & ADRD, we will continue to foster the
development of community-based solutions through the Dementia Friendly Community (DFC)
framework of our outreach and engagement efforts. We will evaluate the impact of these programs on
social constructs that negatively impact disease progression and quality of life, and we will continue
efforts to implement and evaluate the impact of the DFC model in an African American community.